Pivotal Preclinical Studies of Novel Infusible ECM for Treating Acute MI

Summary
Heart failure post-myocardial infarction (MI) continues to be the leading cause of death in the U.S. Each year it
is estimated that ~550K Americans will have a new MI, and ~200K will have a recurrent MI, leading to a large
body of patients suffering from heart failure. These staggering statistics necessitate the development of new
therapies for patients with ischemic cardiomyopathy. Tissue engineering and regenerative medicine strategies
offer significant potential for the development of novel therapies to treat these patients. While cell therapies have
been extensively studied for the treatment of MI and heart failure, meta-analyses of initial cell therapy trials
suggest only a modest effect on cardiac function. More recently acellular biomaterials have shown great promise
in providing similar or greater functional benefit without the complications associated with cell delivery. Injectable
biomaterials that stimulate endogenous repair are an attractive alternative since potential therapies could still be
delivered minimally invasively via catheter yet could be off the shelf and have significantly reduced costs
compared to cell products. Ventrix is therefore focusing on cell-free regenerative medicine approaches. Ventrix
has a history of success in developing injectable biomaterials for treating ischemic cardiomyopathy. Two
previous NIH SBIRs resulted in an approved IND for VentriGel, an injectable, catheter-deliverable hydrogel
derived from decellularized porcine myocardium. This led to a recent successful Phase 1 clinical trial in patients
60 days to 3 years post-MI. We recently developed a new Infusible ECM, for treating acute MI. We showed it
can be delivered to an acute MI via intracoronary infusion and that it improves cardiac function in a rat acute MI
model following simulated intracoronary delivery. In our previous studies, we optimized delivery and retention of
Infusible ECM and demonstrated preliminary feasibility and efficacy in a porcine acute MI model. The studies
proposed in this Phase II project are part of the final steps to initiate studying Infusible ECM in patients, and a
key step in bringing a biomaterial product to market, which will be complementary to existing standard of care.
This will be the first intracoronary infusible regenerative biomaterial product for treating acute MI patients.

Public health relevance
Project Narrative The development of therapies to treat myocardial infarction is a necessity because of the large patient population that declines into heart failure. This proposal seeks to perform final pre-clinical studies to translate a novel catheter deliverable biomaterial therapy for treating acute myocardial infarction.